Rapid and affordable magneto-nanosensors for ctDNA-guided lung cancer management

Project Summary / Abstract
Targeted therapy for the treatment of non-small cell lung cancer (NSCLC) has greatly improved patient outcomes
compared to traditional chemotherapy. However, it is estimated that up to 20% of lung cancer patients receive
first-line therapy prior to EGFR mutational analysis, necessitating the need for a rapid and cheap blood-based
circulating tumor (ct) DNA test for efficient therapy selection. Additionally, ctDNA can be useful for rebiopsy and
monitoring of response to therapy or acquired resistance to therapy. We have successfully developed a highly
multiplexable magneto-nanosensor assay for the detection of “hot spot” mutation panel for lung cancer [targeted
therapy selection or therapy monitoring and prognosis.]
Specific aims of the project are:
1) Validate ctDNA EGFR magneto-nanosensor assay accuracy and correlations to clinical outcome on expanded
cohort. We hypothesize that our magneto-nanosensor assay can detect “hot spot” EGFR mutations Exon19
deletion, L858R, and T790M with high sensitivity and specificity in a large cohort of NSCLC patients. Additionally,
this assay can be well suited for prognosis and therapy response monitoring. A follow-up blood draw 2 weeks
after initiating TKI therapy can be highly predictive of progression free survival. Additionally, we hypothesize that
frequent testing (every 2-3 months) on the magneto-nanosensor assay could be used in lieu of radiographic
imaging if patient maintains favorable response, and that the magneto-nanosensor assay could detect
progression of disease prior to imaging.
2) Develop an extensive ctDNA mutation panel assay on magneto-nanosensor arrays [for NSCLC treatment
selection, monitoring, and prognosis.] We hypothesize that our previously developed EGFR ctDNA magneto-
nanosensor mutation assay can be further expanded to include mutations relevant to third-generation TKI
resistance mechanisms and mutations in other genes to better aid in NSCLC [treatment selection, monitoring,
and prognosis.] In this aim, our goal is to develop a ctDNA mutation panel that can help identify treatment options
for NSCLC patients, not only EGFR mutations but also including KRAS, BRAF V600E, ALK-EML4 fusions, and
ROS1 fusions. [We aim to monitor patients throughout their treatment course for responsiveness and prognosis.]
The expected outcomes of this project are clinical validation of a ctDNA EGFR magneto-nanosensor assay,
expanding and multiplexing the existing EGFR assay to include KRAS, BRAF V600E, ALK-EML4 fusions, and
ROS1 fusions, and utilizing the assay [for efficient therapy selection, prognosis, and/or response monitoring.]

Public health relevance
Project Narrative Targeted therapy for the treatment of non-small cell lung cancer (NSCLC) has greatly improved patient outcomes compared to traditional chemotherapy. However, it is estimated that up to 20% of lung cancer patients receive first-line therapy prior to Epidermal Growth Factor Receptor (EGFR) mutational analysis, necessitating the need for a rapid and cheap blood-based circulating tumor (ct) DNA test for efficient therapy selection. Additionally, ctDNA can be useful for ‘liquid biopsy’ and monitoring of response to therapy or acquired resistance to therapy. We have successfully developed a highly multiplexable magneto-nanosensor assay for the detection of “hot spot” mutation panel for lung cancer targeted therapy monitoring and prognosis. This project is expected to result in clinical validation of a ctDNA EGFR magneto-nanosensor assay, expanding and multiplexing the existing EGFR assay to include Kirsten RAt Sarcoma (KRAS) mutation and certain gene-fusions, and utilizing the expanded assay [for efficient therapy selection and/or therapy response monitoring, and prognosis.]